Novel predictors of survival among breast cancer patients with/without HIV in South Africa

Project Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as
NOT-CA-23-038. In this research and mentoring application linked to our existing R01-funded South African
Breast Cancer and HIV Outcomes (SABCHO) cohort study, Dr Witness Mapanga proposes to conduct a study
to characterize and compare the sociodemographic, clinical, determinants of stage at diagnosis and overall
survival among young women (less than 40 years old) with breast cancer (BC), with and without comorbid HIV.
Dr Mapanga will also assess through in-depth interviews among 30 young women with BC with and without
coexisting HIV, their knowledge and awareness of BC, experiences of their disease and its treatments,
socioeconomical and mental health impacts and support needs at the Chris Hani Baragwanath Academic
Hospital (CHBAH), in Soweto, Johannesburg, South Africa (SA). Dr Mapanga is a young epidemiologist and
public health researcher with experience in cancer and other noncommunicable diseases (NCD), based at the
Strengthening Oncology Services Research Unit (SOSRU) of the University of Witwatersrand (Wits),
Johannesburg, South Africa. His leadership, mentoring and grants acumen development, supported by South
African and international mentoring group, would be an excellent investment for his independent career
development in Southern African cancer research for decades to come. Having completed a PhD in
Epidemiology and postdoctoral Fellowships, he is now ready to establish, lead and sustain his own research
program and supervise embedded postgraduate students.
Dr Mapanga together with his parent grant mentors, Dr Maureen Joffe (SA contact PI and primary mentor),
Professor Dan O’Neil (Medical Oncologist co-I from Yale U, USA), and Professor Shane Norris (SA mentoring
co-I), has developed the research proposal which aims to (i) characterize 480 young women (<40 years of age)
with breast cancer from the SABCHO dataset, comparing the 59% HIV-positive and 41% HIV-negative cases on
sociodemographic, clinical, and treatment factors and overall survival; (ii) compare determinants of the stage at
diagnosis among them and iii) from in-depth interviews with 30 young women (<40 years) with BC (50% HIV-
positive), assess their experiences and impact of BC and its treatments and support needs. To hone Witness’s
supervision skills, he will include in the research, 3 young female cancer specialists at CHBAH who treat our
SABCHO patients to develop manuscripts from research findings and upskill their research acumen. Findings
will support strategies to reduce mortality from breast cancer among young women and reduce disparities to
their early diagnosis and treatment in SA. Dr Mapanga will gain invaluable experience in independently leading
the research project, supervising his mentees, and will receive skilled leadership, supervision, grantsmanship
mentoring and research program development guidance to equip him to establish and lead his own independent
research program within SOSRU.

Public health relevance
Project Narrative SABCHO Mentored Research on Breast Cancer in South Africa Dr Witness Mapanga is a young epidemiologist researcher at the Strengthening Oncology Services Research Unit (SOSRU), University of Witwatersrand, Johannesburg, South Africa. Support to Dr Mapanga would be an excellent investment for his personal career development and through this, for South African and Southern African cancer research for decades to come. He is at the optimal career stage, having a strong academic background (Ph.D. in Epidemiology, and postdoctoral Fellowships) to supervise students and develop his own research program. His proposed study for this NOSI will be on breast cancer among HIV-positive and - negative women less than 40 years old within our parent grant, the South African Breast Cancer and HIV Outcomes (SABCHO) cohort study, aligning with SABCHO goals.